Mid-Atlantic praGmatic NETwork for Inclusive Clinical trials in emergency care (MAGNETIC)

We will create an inclusive and efficient research Clinical Center to conduct pragmatic clinical trials in emergency departments across 7 spoke sites. Our Clinical Center has access to a diverse population of individuals with cardiac and neurologic emergency medical conditions and a host of talented experts. We leverage our considerable institutional research resources, prior relationships, and prior NIH investment. We will bring innovative trial management solutions to the CCC, DCC, the Management and Operations committees, and individual Trial Committees. We have engaged some of the foremost experts from a diverse range of specialties to our Co-Investigator team. Duke's collaborative culture will bring basic science, translational, and clinical researchers to bear on this enterprise. We enlisted 7 high-volume academic health systems as Spoke sites to maximize our opportunities to participate in any proposed trial. All 7 systems are in close geographic proximity and we have previously worked with all Spoke PIs and Co-Investigators. This should lead to significant site-startup efficiency.

Public health relevance
In this collaborative network proposal, we outline a consolidated network of local hospitals representing the community, public, federal, and academic healthcare environments. This network will be supplemented by additional regional and national academic medical centers for additional tertiary care patient enrollment capability.